Regulation of spermiogenesis by Combover and the E3 ligase Mindbomb 2

Project Summary
The ability of an organism to reproduce is one of the essential characteristics that ensure its survival. Any
disruption of the gamete formation results in fertility issues and, in the worst cases, sterility. Due to the
conservation of spermatogenesis across species, Drosophila has been a valuable model for understanding
reproductive biology and fertility. In mammals and Drosophila, a plasma membrane tightly embeds mature
spermatids upon the differentiation and individualization of syncytial spermatids. Elongated interconnected
spermatids begin to separate in a process where specialized actin cones move along the sperm tails removing
inter-spermatid bridges and excess cytoplasm. This individualization process is required for the maturation of
individual and functional spermatids. Previously, it was shown that Cmb, an intrinsically disordered protein,
regulates fertility and the individualization of spermatids. To understand the mechanisms behind Cmb’s
regulation, we will study proteins that Cmb might interact with. From our preliminary data, we know that Cmb
interacts with members of a conserved protein network that are expressed in human spermatids, including the
membrane raft proteins Flotillin 1/2 and E3 ubiquitin ligase Mindbomb 2 (Mib2), as well as with the radial spoke
protein 3 (Rsp3), an axonemal component required for individualization. Interestingly, Cmb colocalizes with
spectrin, a cytoskeletal protein, in the elongation complexes (ECs) at the distal tip of the growing axonemes.
Similarly, Mib2 is also found at the ECs but not simultaneously with Cmb, which might indicate a spatiotemporal
regulation between Mib2 and Cmb. We hypothesize that Mib2 targets Cmb for degradation to coordinate the
transition between axoneme elongation and spermatid individualization. Here, I will determine how and at which
stage Mib2 regulates spermatogenesis and male fertility using immunohistochemistry and a rescue-based
structure-function analysis. To complement this, I will perform live imaging of endogenously fluorescently tagged
Cmb and Mib2 to address their dynamic interplay in localization. Understanding Cmb and Mib2 regulation will
be instrumental in advancing our knowledge of the complex dynamics during spermiogenesis, an unknown
mechanism in all organisms.

Public health relevance
Project Narrative Over the past decades, the quality and amount of male sperm have declined, and male infertility has increased. In this project, I will study how proteins regulate different structures and processes that allow the proper formation of sperm and how their disruption causes male sterility in flies. Understanding the mechanism behind sperm formation will aid in the development of potential male fertility treatments.